CORE--PEPTIDE AND PROTEIN ENGINEERING LABORATORY

The Peptide and Protein Engineering Laboratory (PPEL) provides synthetic peptides, capillary electrophoresis, solid phase sequencing, covalent protein sequencing, amino acid analysis and synthesis of overlapping peptides. It is equipped with a Biosearch/Milligen peptide synthesizer (model 9600), Milligen protein sequencer (model 6600), Advanced Chem Tech multiple peptide synthesizer (model 450), Beckman capillary electrophoresis unit, Waters HPLC workstation (model 820), Beckman HPLCs, lyophilizers, a computer for protein modeling, as well as other requisite support devices.